Sex-dependent microRNA-mediated pathways to chronic musculoskeletal pain following trauma

Abstract
More than 90% of individuals experience a substantial traumatic stress exposure (TSE) in their lifetime. While
most individuals recover following TSE, a substantial subset develop chronic musculoskeletal pain (CMSP).
Despite growing evidence that mechanisms driving CMSP are vastly different in men and women, sex-specific
mechanisms that drive the transition from acute to chronic pain following TSE remain poorly understood. This
lack of knowledge is an important barrier to the discovery of novel therapeutics for the prevention/treatment of
CMSP. The proposed work will help address this barrier by evaluating sex-specific, highly influential microRNA
(miRNA) regulatory mechanisms affecting CMSP development. Experiments will center on miR-19, a miRNA
repeatedly demonstrated to have an important sex-dependent influence on the pathogenesis of chronic pain and
related neuropsychiatric disorders. Based on substantial preliminary data from the investigative team,
experiments will evaluate the overarching hypothesis that miR-19 drives CMSP development differently in men
vs. women via sex-dependent effects on circadian rhythm biology and TLR4-driven innate immune responses.
Proposed experiments will leverage the translational research expertise of the study team by performing
causation and mechanistic studies using both human cohort data and animal model systems. Human cohort
data analyses will include first-in-kind transcriptomic, physiologic, and neuroimmune data collected as part of the
AURORA study, a forty-million-dollar study that enrolled thousands of men and women trauma survivors and
followed them prospectively over the course of one year. Objective accelerometry-based measures of circadian
rhythmicity, measures of immune cell profiling/intracellular signaling (via mass cytometry), RNA and microRNA
sequencing data, cytokine profiles of AURORA samples, and self-report pain and quantitative sensory testing of
study participants will provide a unique opportunity to comprehensively evaluate study hypotheses. In addition,
results from human cohort analyses will be supported by miR-19 knock-down, rescue, and gene expression
studies in a well-validated and robust animal model of TSE-induced enduring stress induced hyperalgesia. By
the end of the award period, we will have gained important new insights into sex-specific mechanisms of CMSP
development and will elucidate exciting new therapeutic strategies for men and women.

Public health relevance
Narrative Chronic pain after traumatic stress exposure is more common in women, and mechanisms of chronic pain development in men and women appear to differ. We propose a series of genomic, molecular, and behavioral studies evaluating how microRNA, master regulators of the mammalian transcriptome, influence chronic pain development after traumatic stress exposure in men and women. These experiments will provide important new insights into sex-specific mechanisms of CMSP development and will identify novel therapeutic strategies for both sexes.